Targeting neutrophil clearance to harness myeloid responses for wound healing.

Targeting neutrophils to harness myeloid responses for wound healing
Chronic wounds represent a significant health problem in the United States. Delayed or non-resolving
inflammation is a hallmark of the chronic wound and is sustained by myeloid cell accumulation and upregulated
myelopoiesis. Metabolic conditions such as obesity contribute to this growing problem and influence myeloid
response to wounds. The central hypothesis of this proposal is that obesity and diabetes dysregulate myeloid
responses and thereby impairs wound healing. Our preliminary study using mouse models suggests a
mechanistic link of neutrophil clearance in the bone marrow with myelopoiesis. We propose a translational study
involving both mouse models and human specimens with three Specific Aims: In Aim 1, we will determine the
mechanism by which neutrophil clearance in the bone marrow regulates myelopoiesis, with the hypothesis that
neutrophils release extracellular vesicles that regulate myelopoiesis during their clearance. In Aim 2, we will
determine the mechanism of inhibited neutrophil clearance in the bone marrow in chronic wounds and obesity,
with the hypothesis that chronic wounds and obesity increase glutamine utilization in neutrophils and inhibit their
clearance in the bone marrow. In Aim 3, we will bioengineer a nano-drug that target neutrophils and modify
myeloid response. To achieve this, we will utilize a well-defined versatile telodendrimer to selectively deliver
glutaminase inhibitor to neutrophils and will test the nano-drug in the preclinical mouse model of impaired wound
healing in obesity. The proposed experiments will improve knowledge of myeloid responses during wound
healing. The impact of these studies lies in the potential for translation to therapies that stimulate healing
responses in hard-to-heal wounds. Also, the studies could lead to the development of assays that involve
monitoring blood neutrophil survival as cellular biomarkers to aid in the selection of treatment options for patients
with chronic wounds and/or obesity.

Public health relevance
Targeting neutrophils to harness myeloid responses for wound healing Project narrative: Chronic wounds represent a significant health problem in the United States with millions of afflicted patients and the associated treatment billions of dollars per year. In the proposed research, we will investigate how chronic wounds and associated obesity dysregulate white blood cells that contribute to the poor healing responses in these conditions. Findings from our experiments will provide insight into whether therapies and tests targeting a type of white blood cells can improve the healing of wounds and can aid in the selection of treatment options that are currently available for treating chronic wounds. The long-term goal of this project is to reduce the socioeconomic burden of chronic wounds and associated obesity and improve the quality of life of these patients.